Culturomic and metagenomic methods optimization to detect multi-strain C. difficile colonization and infection

ABSTRACT
Clostridioides difficile (Cd) infection (CDI) is a leading cause of healthcare-associated infections in the U.S.,
affecting ~450,000 people and costing ~$5.4B annually. Despite substantial advances in investigating Cd
pathogenesis and transmission over the past 20 years, CDI remains a significant public health burden. Recent
studies suggest multi-strain Cd infection is more common than previously recognized and may cause worse
outcomes versus single strain infection. Another recent development is recognition of cryptic clade Cd strains
that can cause CDI but may not be detected with current culture methods or diagnostic assays. A major
impediment to studying multi-strain and cryptic clade Cd colonization and CDI is a lack of validated culture
methods to optimize recovery of more multiple Cd strains or cryptic clade Cd strains. Typically, a single approach
is used to isolate Cd from stool. However, growth of Cd in culture varies by strain, and is impacted by spore
shock method (i.e. ethanol or heat shock), spore germinant (i.e. primary bile salt or lysozyme), and nutrients and
selective antibiotics incorporated into the media. Another challenge to detecting multi-strain colonization and CDI
is the need to type multiple colonies to detect the presence of more than one strain, which can significantly
increase time and costs. In addition, the probability of detecting multiple strains will be dependent on the number
of strains typed. We hypothesize that a combination of Cd culture conditions employed on the same stool
specimen will enhance recovery of multiple and cryptic clade strains of Cd, and that metagenomic approaches
can be used to detect multiple strains from culture and eliminate the need to type multiple colonies. The rationale
for this proposal stems from the need for validated methods to detect the presence of multiple and cryptic clade
strains prior to widespread study of multi-strain and cryptic clade strain Cd colonization and infection. Our central
motivation is that whether multi-strain or cryptic clade strain Cd colonization and infection cause worse outcomes
needs to be confirmed, as this will have a major impact in our understanding and approaches to Cd pathogenesis,
diagnosis, treatment and prevention. We propose to develop methods to optimize detection of multi-strain and
cryptic clade strain Cd colonization and CDI with the following aims: 1.1) Identify the combination of growth
conditions and selective pressures to optimize recovery of multiple and cryptic clade strains of C. difficile from
stool specimens that could be broadly employed to study C. difficile infection epidemiology, diagnosis, treatment,
outcomes, and prevention., and 1.2) Identify the presence and relative abundance of multiple strains of C. difficile
through culture-enriched metagenomic sequencing. Our proposal is significant because validated methods to
detect multi-strain and cryptic clade strain Cd colonization and CDI is a necessary first step to study the
prevalence and outcomes of multi-strain and cryptic clade strain Cd colonization and CDI. Our proposal is
innovative in that it will change the current paradigm of Cd isolation and characterization from stool. The
proposed work is impactful in its goal to develop methods that can be rapidly utilized by multiple investigators.

Public health relevance
Project Narrative Clostridioides difficile infection is an urgent public health threat. Recent studies suggest CDI due to multiple strains of Cd causes worse outcomes than CDI due to a single strain, and current culture methods and diagnostics will miss cryptic clade Cd strains. We propose to develop methods to enhance detection of multi- strain and cryptic clade strain CDI.